Photoredox Catalysis Applications in Organometallics and Chemical Biology

Abstract.
A central goal of our research program is to develop new platforms for the direct conversion of ubiquitous
biomass feedstocks into fine chemical products. In recent years, these efforts have focused on the
application of photoredox catalysis as a uniquely enabling paradigm in synthetic chemistry. The distinct
features of photocatalysts, particularly their ability to readily effect single-electron transfer and thereby
generate reactive open-shell radical species, have created new opportunities for reaction development,
providing novel bond disconnections in synthetic sequences. The application of photoredox catalysis has
been notably successful in the context of metallaphotoredox catalysis, which merges photocatalysis with
transition-metal catalysis. Metallaphotoredox platforms enable non-traditional partners to participate in
cross-coupling chemistry. Our group and others have used metallaphotoredox catalysis as a means to
address many long-standing challenges in synthetic organic chemistry. This research proposal outlines new
fields in which photoredox approaches have the potential to achieve significant impact. The objective of
Research Program I is to develop new photoredox-mediated methodologies that proceed through a radical
sorting / bimolecular homolytic substitution pathway. Successful execution of this program could
theoretically allow selective coupling of virtually any two functional groups. In Research Program II, we
propose to harness metallaphotoredox catalysis to develop new transformations that are not attainable via
thermal pathways. Progress in this area would unlock new reactivity profiles, including carbenoid
reactivity. Finally, Research Program III aims to make significant advances in our longstanding goal of
converting feedstock chemicals to reactive radical intermediates. A focusing objective of this program is to
establish alcohols as general cross-coupling handles for the installation of medicinally relevant
functionality.

Public health relevance
Project Narrative A longstanding goal of our research program is to develop new platforms to harness ubiquitous native functional groups as simple precursors for complex organic frameworks. In recent years, these efforts have focused on the application of photoredox catalysis as a uniquely enabling paradigm in synthetic chemistry. We aim to harness this visible light-driven catalytic platform to gain facile and efficient access to biologically active compounds of high interest.